POST BONE MARROW TRANSPLANT LUNG INJURY PATHOPHYSIOLOGY

DESCRIPTION (Adapted from the applicant's abstract) The overall goal of this application is to identify important donor and host factors which are critical to the pathogenesis of IPS occurring BMT. This group has chosen to use murine BMT model systems which provide great flexibility in the choice and manipulation of the host and/or donor under highly controlled genetic and environmental conditions. They will focus their proposal on the early post-BMT events which initiate the IPS generation process since they hypothesize that the initial inflammatory and immune- mediated destructive events are critical to the subsequent development of IPS. They will first obtain important information on the early post- BMT events which trigger and/or amplify IPS generation, focusing on the role of conditioning on tissue damage, acute phase response to tissue injury, and immune mediated cellular destruction which cumulatively lead to IPS. Using a uniform and commonly used conditioning regimen consisting of cyclophosphamide (Cy) + total body irradiation (TBI), they will proceed in a step-wise fashion to eliminate or reduce a limited number of soluble acute phase reactants in this setting. The contributions of leukocyte migration in the acute inflammatory phase of IPS generation will be examined. They will then proceed with studies designed toward improving the understanding of the immune mediated destructive events which are particularly prominent in allografted recipients. All of these studies will be accomplished primarily through the use of mice with gene deletions as a means of definitively including or excluding various potential contributory factors to IPS. Importantly, all of the deletional strains discussed below have been provided to us on a single genetic background (C57BL/6), which is their preferred strain since C57BL/6 mice have been used in the vast majority of all of their BMT experiments performed to date. These strains are currently being bred in their specific pathogen-free colony and will, therefore, permit investigations of IPS in the complete absence of viral pathogens, which would complicate the interpretation of their experiments. If successful, their approaches may be important clinical implications for the potential therapeutic intervention in human BMT recipients at high risk for IPS.